QUALITY OF DYING AND DEATH IN PERSONS WITH AIDS

QUALITY OF DYING AND DEATH IN PERSONS WITH AIDS aims are to l) use qualitative interviews and draft questionnaire to develop and select items for an instrument administered to loved ones and health care providers after a patient's death from AIDS that can be used in evaluation of the quality of dying and death; 2) assess the psychometric properties (measurement model, internal consistency, discriminate validity, and convergent validity) and respondent burden of the instrument; 3) compare physician\casework evaluations with that of family and friends. Up to 3 loved ones and 3 health care workers will be interviewed following the deaths of up to 40 persons with AIDS to elicit domains and items that evaluate the quality of dying of death of the person with AIDS and to pilot existing questions. Respondents will be asked to describe last 7 days of person's life in detail. Content of final instrument to be determined by psychometric evaluation of existing items, new domains and items, and comparability among loved ones and health care workers.